Mentoring & Patient-Oriented Research in Sickle Cell-Related Kidney Disease

The overall goal of this K24 application titled “Mentoring & Patient-Oriented Research in Sickle Cell-Related
Kidney Disease” is for a mid-career hematologist and physician-scientist, Santosh L. Saraf, MD, to develop
necessary skills to mentor the next generation of junior investigators focused on sickle cell disease (SCD)-
related research. Chronic kidney disease develops in over half of adults with SCD and leads to increased
morbidity and early mortality. The mechanisms for how chronic kidney disease develops are, unfortunately,
poorly understood and therapies to prevent and treat sickle cell nephropathy are urgently needed. Further
complicating the care of individuals with sickle cell disease is the dearth of clinicians focused on SCD-related
research and clinical care. The applicant’s goals for this K24 award are to train the next generation of clinician
scientists by leveraging preliminary work and multi-center collaborations of carefully phenotyped SCD cohorts
to identify high-risk patients and targetable pathways for SCD-related kidney disease. The applicant has
demonstrated that chronic exposure of the kidneys to cell-free hemoglobin and heme are associated with
progression of chronic kidney disease. The new research that is proposed in this award is a natural extension
of Dr. Saraf’s ongoing work and consists of investigating 1) whether genetic variation of the haptoglobin allele
and heme oxygenase-1 GT-repeats predicts chronic kidney dysfunction and its progression and 2) if
complement activation is implicated in the pathophysiology of cell-free hemoglobin catabolism and SCD-
related kidney disease. Several of Dr. Saraf’s active and completed projects have developed longitudinal SCD
cohorts with harmonized phenotypes, including kidney, heart and lung function. These cohorts are available for
mentees to address the research aims in this proposal as well to develop their respective independent
research trajectories. Dr. Saraf will apply several resources available at the University of Illinois at Chicago,
such as T35, TL1, R38, and KL2 programs, to train and produce outstanding clinical scientists. Dr. Saraf has a
strong record of funded clinical research and mentoring trainees but requires additional protected time and
training to become an inspiring mentor for this underserved and high-risk patient population. The K24 award
will provide Dr. Saraf with the additional time and resources to amplify his efforts in understanding risk factors
and targetable pathways for SCD-related chronic kidney disease and in training the next generation of clinician
scientists in SCD-related research and clinical care.

Public health relevance
Project Narrative Sickle cell disease is among the most common monogenetic diseases worldwide and chronic kidney disease, which occurs in more than half of adults with sickle cell disease, is associated with high mortality. The goals of this proposal are to expand the applicant’s current research and mentoring program to identify whether key genetic variants associated with impaired cell-free hemoglobin and heme processing can identify patients at increased risk for progression of chronic kidney disease and if complement activation is involved in the pathophysiology of kidney dysfunction in sickle cell disease. The applicant has a strong foundation of mentoring trainees and junior faculty and proposes to utilize currently funded research as well as the proposed project to augment his mentoring capacity and develop junior investigators focused on sickle cell disease- related research.